Training Grant in Clinical Pharmacology

ABSTRACT
This proposal represents a request for continued funding of the NIH-sponsored Clinical Pharmacology
T32 Fellowship Training Program at the Mayo Clinic. The foundation for this program is strong training in
state-of-the-art biomedical research as applied to human-drug interactions. The Mayo Clinical Pharmacology
training experience includes a curriculum that systematically exposes Trainees to critical aspects of the
science that underlies Clinical Pharmacology. However, beyond the formal curriculum, at the heart of the
training is an outstanding individual research experience within a supportive mentoring environment.
Clinical Pharmacology is a “bridge discipline” devoted to studies of the interaction between drugs and
biological systems. However, within the context of the ongoing “revolution” that is occurring in biomedical
science, a revolution that promises to transform medical practice, Clinical Pharmacology lies at the
confluence of molecular pharmacology, genomics and other “omics” disciplines. In addition,
increasingly, bioinformatics, systems pharmacology and novel computational methods are also
becoming critical compotents of Clinical Pharmacology—with an ultimate goal of truly “individualized”
and rational drug therapy. Specifically, Clinical Pharmacology seeks to enhance our understanding of the
molecular basis for drug response and the application of that information at the translational interface to make
it possible to tailor drug therapy to both the underlying disease process and the unique characteristics of each
individual patient. Our ability to take advantage of the opportunity represented by the dramatic advances
that are occurring in biomedical science to achieve that “ultimate goal” will require that we train a new
generation of Clinical Pharmacologists in “Systems Clinical Pharmacology”. Large, comprehensive,
integrated academic medical centers like the Mayo Clinic are ideally positioned to train this new generation of
Clinical Pharmacologists. Mayo is able to do that because of its long history of supporting and performing
outstanding basic and clinical medical research and of integrating the two. Mayo also has a long tradition of
contining contributions to the discipline of Clinical Pharmacology as well as decades of experience in
successfully recruiting and training both physician scientists and laboratory-based translational scientists in
Clinical Pharmacology. During the next funding cycle, the Mayo Clinical Pharmacology Fellowship Training
Program will continue to emphasize strong laboratory-based research training in a supportive mentored
environment joined with a strong and evolving curriuculum and systematic exposure to novel developments in
clinical science, with an emphasis on the rapidly advancing nature of biomedical science—all directed toward
the goal of preparing each Fellow enrolled in the Program to become a future leader in Clinical
Pharmacology.

Public health relevance
NARRATIVE This proposal is a request for continued NIH funding of the Clinical Pharmacology T32 Fellowship Training Program at the Mayo Clinic. Clinical Pharmacology is the science that encompasses all aspects of the use of drugs or biological therapeutic agents to treat human disease. The rapid pace of the evolution of modern biomedical science has created unique opportunities to develop new and powerful drugs to treat disease, but in order to take advantage of those opportunities, we must train the next generation of Clinical Pharmacologists so they can assist and accelerate these advances—exactly the goal of the Clinical Pharmacology Fellowship Training Program at the Mayo Clinic.